Developmental infant effects of exposure to high doses of oral insulin in human milk

PROJECT SUMMARY/ABSTRACT
1 This proposal utilizes cutting-edge mechanistic approaches to investigate the clinically meaningful but hard-to-
2 study question of HOW insulin in human milk affects infant development. This research question is particularly
3 relevant to the growing and under-studied population of infants receiving breast milk from obese and/or insulin
4 resistant (IR) mothers - who produce milk with significantly greater insulin concentrations. Animal models show
5 that oral insulin delivered to the infant via breast milk has far-reaching effects on normal offspring development
6 and maturation. This proposal documents these effects in human infants and investigates how effects may be
7 altered in the context of maternal IR - and thus sustained infant exposure to high concentrations of oral insulin.
8 Specifically, we examine systemic effects regulated by infant pancreatic function as well as local intestinal
9 effects. Importantly, we will document both acute effects during the neonatal period when organs are still
10 immature AND effects of more “chronic” exposure. We will recruit 64 exclusively breastfed infants of both
11 normal weight/normoglycemic (NW; n=28) and IR (n=36) mothers and study them during the neonatal period
12 (2-4 weeks) and after more “chronic” exposure to mother’s milk (5 months). Our aims are:
13 Aim 1 – Cross-Sectional Study – Investigate differences in metabolic development and intestinal maturation
14 between infants exclusively breastfed by NW vs IR mothers at two critical time points: 2-4 weeks and 5
15 months. We hypothesize that infants breastfed by IR mothers will exhibit: an altered metabolomic profile
16 indicating differences in carbohydrate handling and insulin signaling (H1.1); an altered microbial composition in
17 the intestinal microbiome (H1.2); increased relative transcript abundance of insulin-target genes in exfoliated
18 intestinal cells, indicating more active insulin signaling at the level of the enterocyte (H1.3); and decreased
19 intestinal permeability (a functional measure of intestinal maturation) at 2-4 weeks (H1.4).
20 Aim 2 – Glycemic Study - Determine if consumption of human milk from an IR mother (with high concentrations
21 of insulin) is correlated with differences in endogenous pancreatic response at 2-4 weeks. We hypothesize that
22 receipt of human milk with high insulin will result in a lower endogenous pancreatic insulin response (H2.1).
23 Aim 3 – Glucose Tolerance Study - Determine if chronic consumption of human milk from an IR mother (with
24 high concentrations of insulin) is correlated with pancreatic response to a glucose challenge at 5 months. We
25 hypothesize that chronic exposure to human milk from an IR mother will under-stimulate pancreatic β-cells and
26 result in a dampened endogenous insulin response to a standard glucose challenge at 5 months (H3.1).
27 Our long term objective is to fully understand the impact of oral insulin in the development and postnatal
28 programming of the breastfed infant. As the prevalence of insulin resistance rises among mothers – and as
29 these women’s offspring have increased risk of developing metabolic disease themselves – this work has far-
30 reaching implications regarding how we counsel women and care for their infants to minimize disease risk.

Public health relevance
PROJECT NARRATIVE Insulin-resistance has become commonplace, and results in very high insulin concentrations in breast milk. This study investigates how high breast milk insulin may affect infant development through a number of mechanisms. The study design uses multiple non-invasive approaches and cutting-edge technologies to investigate how breast milk from an insulin-resistant mother may cause postnatal programming.